Biophysical studies of viral membrane fusion proteins

SUMMARY
Influenza A virus (IAV) hemagglutinin (HA) is the canonical example of a class-I viral fusion protein, and thus
provides an ideal model system for understanding the fusion mechanisms of many different viruses. Numerous
other viral envelope glycoproteins, including the SARS-CoV-2 spike, are believed to mediate fusion by a
comparable mechanism. Our long-term goal is to establish a complete mechanistic framework of class-I viral
fusion. We further aim to identify conserved and divergent features of the fusion mechanisms of distinct viruses,
generating specific models that fit within the general framework. HA resides on the surface of the IAV virion and
facilitates attachment to the target cell surface through the receptor-binding domain (HA1) engaging SA moieties.
Following endocytosis and trafficking to the late endosome, HA promotes fusion of the viral and endosomal
membranes. The model of HA-mediated membrane fusion describes a “spring-loaded” metastable prefusion
conformation at neutral pH. Dissociation of HA1 from the fusion domain (HA2) allows HA2 to undergo a cascade
of conformational changes that drive membrane fusion. While extensive structural data exist for HA pre- and
postfusion, and alternative conformations have been visualized and inferred, the conformational trajectory that
leads to membrane fusion, including the adoption of anticipated intermediates, has never been explicitly
validated. Nor has the order and timing of conformational changes and membrane fusion been determined. Here,
we will utilize a multifaceted approach involving single-molecule Förster resonance energy transfer imaging,
single-virion fusion, cryoelectron tomography, and molecular dynamic simulation to directly visualize the
conformational trajectory undergone by HA during membrane fusion. We will explore the roles of virion
morphology, HA density and cooperativity, and target membrane lipid content in mediating HA conformational
changes and the mechanism of fusion. We will describe the allosteric connection between distal regions of HA
that regulate the timing of fusion, drawing comparison to SARS-CoV-2 S. Finally, we will biophysically
characterize the phenotypic differences between human and avian IAV strains to determine what prevents avian
IAV strains from entering the human population.

Public health relevance
NARRATIVE Influenza hemagglutinin is a model system for studying the mechanism by which enveloped viruses fuse membranes during entry into cells. The proposed research will lead to a better understanding of the mechanism of influenza and SARS-CoV-2 entry, specifically, and class-I viral membrane fusion in general. We will also biophysically evaluate avian influenza strains, as well as human pandemic strains that originated in birds to determine the mechanistic features that avian strains must acquire to infect humans.